Core C: Community Engagement Core

PROJECT SUMMARY/ABSTRACT – COMMUNITY ENGAGEMENT CORE
N-Nitrosamines are a family of chemicals that include some of the most potent mutagens known. N-nitrosamines
are a major concern for people who live near the Olin Chemical Superfund Site, because there is a plume of N-
nitrosodimethylamine (NDMA) contamination of water and soil that stretches nearly a mile underground,
contaminating municipal and private wells. NDMA is also a concern of the Passamaquoddy Tribe, because the
methods used for water treatment are known to lead to formation of NDMA. Over many years, the MIT team has
created strong relationships based on trust and mutually shared goals, and these relationships are the basis for
ongoing and proposed work. Via bi-directional communication and collaboration with stakeholders, the CEC
plays a vital role in accomplishing its mission of educating youth in environmental health sciences, inspiring
research careers and social responsibility for the next generation of scientists, and reducing the amount of N-
nitrosamines in drinking water. Specific Aim 1 is to teach. Working with BMR Projects 1 and 2, the CEC will
create innovative, hands-on learning experiences that teach key concepts of biology and environmental
health sciences. Working with the tribal educators (Culture Keepers), the MIT team will co-create and distribute
hands-on experiential learning kits to teach key concepts of biology and environmental health to Tribal Youth.
The CEC will also work with high-school teachers in Wilmington to optimize hands-on teaching experiences for
Wilmington high-school teachers to share knowledge related to the research focus of the MIT SRP Projects 1
and 2. Using tactile teaching kits, the MIT SRP will address the pipeline problem by co-creating and offering
teaching experiences to underrepresented minority (URM) individuals to inspire careers in environmental health.
Specific Aim 2 is to intervene and prevent disease by working with all Projects to empower stakeholders
to reduce the levels and toxicity of hazardous substances. The CEC will partner with community
stakeholders to better communicate with organizations that can help to provide cleaner water, including the EPA.
In addition, to reduce the levels of toxicants, the CEC (with support from the Environmental Science and
Engineering [ESE] Projects 3 and 4), will team up with a non-profit organization that teaches tomorrow's leaders
in industrial chemistry to adopt strategies that reduce and prevent environmental contamination. Specific Aim
3 is to support the use technology that will be developed by ESE Projects 3 and 4 to perform Citizen
Science and provide filtration devices to the community. Data on the identity and the levels of N-
nitrosamines will be collected by the CEC in collaboration with community members via a Citizen Science project.
Data on the levels of N-nitrosamines will be integrated with data from the other Projects and Cores to contribute
to risk evaluation. The CEC will also help to deploy a novel filtration device that destroys N-nitrosamines. By
empowering people with knowledge of what is in their water and by offering filtration devices, the CEC will reduce
the amount and toxicity of hazardous chemicals in drinking water.

Public health relevance
PROJECT NARRATIVE – COMMUNITY ENGAGEMENT CORE The mission of the MIT Superfund Research Program (SRP) Community Engagement Core (CEC) is to continue to strengthen robust bidirectional communication and collaborations with stakeholders that will make it possible to be responsive to the needs of community members by reducing the amount and toxicity of hazardous chemicals in the environment. The CEC will use tactile learning kits (invented by the CEC leader) to teach community members about how environmental chemicals can cause cancer and will work with educators to inspire underrepresented students to pursue research careers in environmental health. Working with the EPA, community members, and other MIT SRP members, the CEC will do Citizen Science research to reveal the amount of contamination in water, and will provide filters that will reduce the amount of hazardous chemicals in drinking water.